Validation of a pediatric thrombosis risk assessment model and characterization of bleeding in hospitalized children through the Children's Hospital Acquired Thrombosis (CHAT) Consortium

PROJECT SUMMARY/ABSTRACT
Venous thromboembolism (VTE), a serious and life-threatening condition, has increased in incidence for
hospitalized pediatric patients by 200%. This has led to increased morbidity, mortality and longer hospitalizations,
and is thought to be due to more effective care of children with serious and life-threatening disorders.
Unfortunately, it is unclear which children are at the highest risk of hospital acquired (HA) VTE and how to prevent
these events due to many studies being single center with small case numbers. My parent K23 addresses the
critical need to identify children at a high risk of HA-VTE, but a low risk of bleeding, using a risk assessment
model (RAM). The study cohort will be used as the target population for trials evaluating the efficacy and safety
of prophylactic anticoagulation to progress towards the long-term goal of HA-VTE prevention in children. This
Administrative Supplement application focuses on the third research aim, to explore barriers to provider
engagement with RAM implementation by conducting focus groups and semi-structured interviews of
inpatient medical teams using qualitative thematic analysis strategies. The other objectives of this K23
award are to (1) prospectively validate a pediatric HA-VTE RAM created through my multi-center Children’s
Healthcare Advancements in Thrombosis (CHAT) Consortium using a case-control study design and electronic
medical record review (EMR) and (2) evaluate the incidence and characterization of bleeding in hospitalized
children on and off anticoagulation through EMR review. In order to achieve these research aims, I previously
outlined my short-term career goals to obtain new knowledge, skills, and experience that will allow me to (1)
analyze data from large datasets from multicenter studies and build and validate risk models through multivariate
analysis; (2) develop qualitative research skills to design and analyze focus groups and semi-structured
interviews (the focus of this application); and (3) acquire the knowledge to plan and conduct randomized
controlled trials. Achieving these career goals will support my long-term career goal of becoming an
independently funded, leader in the effort to determine efficacious and safe VTE prevention strategies in children
through multicenter randomized controlled trials. I will accomplish my aims with the support of my local mentor,
Dr. Aristizabal (qualitative methods expert), who will help lead the team with mentor, Dr. Young (pediatric
thrombosis clinical researcher), and co-mentors, Dr. Goldenberg (pediatric clinical trial researcher), Dr.
Amankwah (epidemiologist and biostatistician) and Dr. Zakai (adult thrombosis clinical researcher). My plan for
career development is enhanced by the outstanding research environment at the University of California, San
Diego, Rady Children’s Hospital, which provides junior faculty members with numerous didactic and training
opportunities designed specifically to facilitate the transition to research career independence. By completing my
research and training aims, I will take the first necessary step in identifying children at high risk of HA- VTE who
may safely benefit from prevention strategies and subsequently reduce the incidence of pediatric VTE.

Public health relevance
PROJECT NARRATIVE Hospitalized children who develop a venous thromboembolism (VTE), a blood clot in the deep veins or pulmonary vasculature, have an increased risk of morbidity from long term pain and venous insufficiency, as well as increased mortality. The lack of established methods for assessing VTE risk or applying safe and effective VTE prevention strategies as a standard component for hospitalized children has led to the increasing incidence of hospital-acquired VTE. Completing the overall aims of this parent K23 award will contribute to the NIH mission to apply scientific knowledge to enhance health, lengthen life and reduce illness and disability in children through establishing a validated pediatric VTE risk assessment model and identifying barriers to hospital staff implementing risk models to create safe thromboprophylaxis methods.